UAB Center for AIDS Research (CFAR)

PROJECT SUMMARY
Overall
The Center for AIDS Research (CFAR) at the University of Alabama at Birmingham (UAB) catalyzes new and
nurtures ongoing HIV research – across domains of basic, behavioral, clinical, implementation, and community
science – in partnership with the communities we serve. As a nexus for HIV research since inception in 1988,
the CFAR now provides support in the form of 18 research services, pilot funding, investigator development, and
foundational relationships with community partners. Under new leadership since July 2022, we have carried out
a robust, forward-looking strategic planning process yielding a structure with 5 Cores (4 continuing/refreshed:
Administrative, Developmental, Clinical, Advanced Technology; 1 new: Implementation & Community Sciences)
and 2 new Scientific Working Groups (Substance Use and Global Health Reciprocal Innovation). Changes align
with current priorities for HIV research and will facilitate advances in implementation and community sciences
while sustaining excellence in basic and clinical research.
Our CFAR shared values are to center and grow diversity, equity, inclusion, and access and to be in authentic
partnership with communities most impacted by HIV. The center includes >165 active HIV investigators,
partnerships with 13 community based organizations and 4 academic institutions, and leadership that
purposefully incorporates diverse mid- and senior-level investigators. In 2022, the center’s HIV federal research
base (FRB) was $23 million, and the university received $66 million in total HIV funding. The FRB includes 79
grants (up 30 from the last renewal application). Our return on investment from pilot grants is now $17:1 (up $4)
and the center participated in recruiting 41 HIV investigators (21 new to UAB, 20 from UAB new to HIV research,
27 women, 7 underrepresented minorities) in the current funding cycle.
Over the next 5 years, we will leverage our Cores and SWGs to: 1) provide robust services to the HIV research
community that add value to cutting edge science, including through technologies, data science, and
methodologic expertise; 2) catalyze innovation and develop integrated networks of researchers and funded
research focused on HIV and a) substance use and b) global health reciprocal innovation; 3) develop and
nurture a diverse next generation of HIV researchers, including those across a wide spectrum of lived
experience and career paths; and 4) sustain and strengthen authentic bi-directional relationships between
CFAR investigators and communities most impacted by HIV.
Through our structure, relationships with community, public health, and academic partners, and institutional
support, the UAB CFAR is positioned to support high-impact discoveries towards the achievement of HIV
research priorities and curbing the epidemic in Alabama, the Deep South, and globally.

Public health relevance
NARRATIVE Overall The UAB CFAR catalyzes new and supports ongoing HIV research across all domains – in partnership with communities most affected by HIV. Through our structure, relationships with community, public health, and academic partners, and institutional support, we are positioned to support high-impact discoveries towards the achievement of HIV research priorities and curbing the HIV epidemic in Alabama, the Deep South, and globally.